MUSICO: An in silico platform for evaluating the effects of disease and drug effectiveness in HCM and DCM cardiomyopathies

SUMMARY ABSTRACT
Cardiovascular diseases, including hypertrophic and dilated cardiomyopathies (HCM and DCM), are leading
global causes of death, imposing significant societal and economic burdens. Current therapies focus primarily
on symptom management rather than addressing root causes. Mutations within sarcomeric proteins, which
account for approximately 30-60% of cardiomyopathies, emphasize the critical role of acto-myosin interactions
and sarcomere regulation in these conditions. Despite this understanding, developing effective treatments
remains costly, prone to late-stage failures, and limited in predicting outcomes in humans. There is an urgent
need to identify and eliminate ineffective drug candidates earlier in the development process. To address these
challenges, we present MUSICO (MUscle SImulation COde), a state-of-the-art in silico platform designed to
integrate diverse experimental data and predict muscle behavior across multiple scales and species, from
molecular interactions to whole heart function. The platform incorporates “translational matrix” (TM) method,
effectively converting in vitro animal model data into relevant human in vivo insights, enabling comprehensive
data utilization and robust cross-species correlations. This project (Phase 1) aims to demonstrate the MUSICO
platform’s predictive capabilities for four novel drugs currently in various stages of development, preparing it for
commercial drug discovery applications. Specifically, we will conduct rodent studies using demembranated
trabeculae measurements, force-pCa, and intact twitch measurements, as well as twitch experiments with
human-induced pluripotent stem cell-derived cardiomyocytes (hiPSC-CM) and engineered heart tissue (EHT).
Additionally, we will collect crucial data from porcine heart muscles through X-ray diffraction experiments (Aim
1). These experimental data will be integrated with MUSICO simulations to validate the platform’s accuracy in
predicting the effects of myosin activators Danicamtiv (Dani) and 2’-deoxy-ATP (dATP) for treating DCM, and
Aficamten (Afi) and a novel myosin inhibitor (RLC-1) for treating HCM (Aim 2). Finally, we will develop a
commercialization strategy, including establishing connections with potential clients such as pharmaceutical
companies, CROs, and academic labs (Aim 3). This will strongly enhance our capabilities for Phase 2 of the
SBIR program. The extensive simulations conducted in Phases 1 and 2 will enable the creation of a standardized
database, automating predictions and providing valuable insights into the effects of genetic mutations and drugs,
ultimately guiding more effective treatment strategies for cardiomyopathies. MUSICO has already shown
promise in accurately predicting muscle behavior affected by mutations and drugs before experimental
confirmation. We successfully demonstrated the mechanism of mavacamten action even before it was
experimentally confirmed. By reducing reliance on animal and human trials and translating data across species,
this project will further establish MUSICO’s potential as a powerful tool in drug discovery and personalized
medicine.

Public health relevance
PROJECT NARRATIVE Cardiomyopathies, including HCM and DCM, are major causes of morbidity and mortality worldwide, largely driven by genetic mutations in sarcomeric proteins. Effective treatments are hindered by slow and costly drug development processes. FilamenTech’s MUSICO platform provides a transformative solution, using in silico modeling to integrate experimental data and predict drug effects early in development. By reducing reliance on traditional methods, we aim to accelerate the discovery of effective treatments for cardiomyopathies, improving patient outcomes and reducing healthcare costs.